IGF::OT::IGF SPECIAL STUDIES/ANALYSIS- CHEMICAL/BIOLOGICAL

This agent is being developed in support of ongoing Phase I/II clinical trials, therefore these supplies are needed to support the human clinical trials. In support of the GMP production of this agent, following tasks need to be carried out: